(REDS-IV-P) RECIPIENT EPIDEMIOLOGY AND DONOR EVALUATION STUDY IV-DATA

The goal of the REDS program is to evaluate and improve the safety and availability of the blood supply and the safety and effectiveness of transfusion therapies. The program also works to proactively address potential emerging threats to the Nation's blood supply and serves as a resource for ongoing work in transfusion research. Now in its fourth phase, the Recipient Epidemiology and Donor Evaluation Study-IV-Pediatric (REDS-IV-P) program aims primarily at improving the benefits of transfusion while reducing its risks; the REDS program also has a new focus on previously understudied populations. Over the past 30 years, REDS has been the premier research program in blood collection and transfusion safety in the United States. In its third phase ? REDS-III ? the program focused on conducting research on all elements of the transfusion chain, from the blood donor to the blood products made from their donation to the adult patients receiving the products through transfusion. REDS-IV-P builds on REDS-III with an additional focus on research with newborns, children, and pregnant women who need transfusions. The data compiled in REDS-IV-P will allow investigators to rapidly address key research questions in transfusion medicine and inform blood policy decisions, for adults as well as for children and other understudied patient populations. REDS-IV-P also extends the Brazilian sickle cell disease cohort that was established in REDS-III to evaluate transfusion practices and associated clinical outcomes in sickle cell disease. The REDS-IV-P Brazilian transfusion program will also continue its monitoring and surveillance efforts for Zika, chikungunya, dengue, and other emerging viral threats to the blood supply. The purpose of this modification is to obligate FY 2020 NICHD funds to support the Domestic Hubs moderate security environment and support any Phase 1 pediatric/neonatology efforts. Specific Aims Coordinate REDS-IV-P activities and participate as a member of the Domestic and Brazil Steering Committees to develop and implement a coordinated plan to achieve program objectives. The Contractor shall develop Operating Procedures for the REDS-IV-P program in the first six months of the contract period in cooperation and consultation with the REDS-IV-P Steering Committees, Executive Committee, and NHLBI. Establish a single/central IRB charged with conducting the ethical review required by the Department of Health and Human Services regulations for the Protection of Human Subjects for multi-center non-exempt human research conducted by the Domestic REDS-IV-P program and manage and maintain all relevant records. Develop a public and private REDS-IV-P website. Develop and finalize the protocols and associated Manuals of Operations for the cumulative centralized databases. A centralized and cumulative donor, and donation database shall also be developed and maintained by the Contractor for the REDS-IV-P Brazil program. The period of data collection for these cumulative databases will be determined by the Brazil Steering Committee with NHLBI but is anticipated to include about 5 calendar years of data (2019-2023).